Delayed Cord Clamping with Oxygen In Extremely Low Gestational Age Infants (DOXIE)

Background: Current newborn care practice is to delay clamping and cutting the umbilical cord to allow for
hemodynamic stabilization. Supported by numerous randomized controlled trials and meta-analyses, delayed
cord clamping (DCC) is endorsed by both neonatal and obstetrical governing bodies. Limited oxygenation data
on DCC in extremely preterm infants suggests they remain hypoxic immediately after birth. This may be due to
differences in how infants transition during DCC. Immediately after delivery, extremely preterm infants attempt
to initiate lung aeration and gas exchange. Animal studies have demonstrated that delaying clamping of the
umbilical cord until breathing is established avoids adverse cerebral and cardiac hemodynamics, which may
reduce bleeding in the brain, including severe intraventricular hemorrhage (sIVH). In a multicenter trial comparing
DCC to umbilical cord milking, 76 percent of preterm newborns between 230-276 weeks gestation who received
DCC without respiratory support initiated respirations prior to cord clamping, yet still had relative hypoxia
demonstrated by a low 5-minute arterial oxygen saturation (SpO2 73 percent (95% CI 71.4, 75.6)). Two recent
analyses found that preterm infants with a 5-minute SpO2 < 80 percent were more likely to have sIVH or
death. Supplemental oxygen provided during DCC with resultant lung aeration may decrease significant
morbidities and death in extremely preterm infants. A pilot study with detailed assessments of hemodynamics
and organ function immediately after birth is needed to determine the efficacy and safety of providing 100 percent
oxygen during DCC.
Design: This randomized double-blinded pilot trial will enroll 140 extremely low gestational age infants (230-
276 weeks gestation) who receive DCC of at least 60 seconds with carefully detailed hemodynamic assessments
and simultaneous video recordings. The study will evaluate infants providing continuous positive airway pressure
(CPAP) and/or positive pressure ventilation (PPV) by face mask with an inspired fractional oxygen (FiO2) of 1.0
(HI Group) during DCC compared to infants given mask CPAP/PPV with an inspired FiO2 of 0.30 during DCC
(LO Group). Due to the nature of the intervention, both arms receive CPAP/PPV with identical cord clamping
times and respiratory support, the study can be blinded by covering the oxygen blender, avoiding any postnatal
treatment bias. Once the cord is clamped and cut, each infant is resuscitated as per usual protocol (CPAP/PPV
with a starting FiO2 0.30) by the clinical team. We will collect physiological parameters from birth through the first
24 hours of life (including detailed breathing assessments from video recordings at birth/ resuscitation suite). If
we reduce hypoxia in extremely preterm infants by providing supplemental oxygen during the period of delayed
cord clamping, there may be a dramatic reduction in morbidity and mortality. Depending on the findings, results
will be used to design a more definitive larger, multicenter R01 trial powered for important clinical outcomes such
as severe IVH or death and neurodevelopmental outcomes.

Public health relevance
PROJECT NARRATIVE Current newborn care practice is to delay clamping and cutting of the umbilical cord to allow additional blood flow to vital organs. However, delaying respiratory support and not providing sufficient oxygen during this period may be harmful in extremely preterm infants. Providing supplemental oxygen to extremely preterm infants during delayed cord clamping may potentially improve transition at birth and prevent newborn disorders and disabilities with lifelong consequences and/or death.